Cortical circuit dynamics underlying multisensory decision making

Project Summary
To navigate and guide locomotion in a complex 3D environment, humans and animals must make countless
judgments of their direction of self-motion, or heading. Each of these is a multisensory perceptual decision,
able to achieve greater accuracy and precision by combining signals from the visual, vestibular, and
kinesthetic senses. At the same time, the brain must decide when to commit to a course of action (e.g., to
quickly change direction to avoid an obstacle), and make predictions of the likelihood of success in that
action. These features of a decision—choice accuracy, response time (RT), and confidence—have been
studied by psychologists for over a century, but primarily for only a single modality, instead of the more
natural case of integrating multiple sources of sensory evidence. Moreover, the neural basis of multisensory
integration is largely studied at the level of individual cells or brain regions, whereas nearly all perceptual and
cognitive functions depend on population-level computations and communication between areas. To address
these gaps, we trained monkeys to perform a visual-vestibular heading discrimination task which measures
choice, RT, and confidence via a post-decision wager (PDW). During performance of the task, we will record
ensemble activity simultaneously from two key nodes in the sensory cortical network representing visual and
vestibular self-motion cues (MST and PIVC, respectively), as well as one node (lateral intraparietal area, LIP) in
the downstream decision network that converts sensory evidence into a motor plan. These regions have
individually been linked to heading perception, but little is known about how their coordinated activity
patterns, observable only though population recordings, support multisensory decision making. In Aim 1 of
the proposal, we will quantify the coordinated activity across sensory neural populations and test whether the
perceptual improvement from multisensory integration depend on the strength of coupling between them,
beyond what can be explained by their activity considered independently. When visual and vestibular cues
are artificially placed in conflict, we will ask whether and how the relative precision of heading estimates
decoded from these sensory populations predicts choice and confidence, guided by predictions of a
multisensory evidence accumulation model. In Aim 2, we will extend our investigation of inter-areal
interactions to the decision stage, quantifying the strength and timing of functional coupling between LIP and
each of the two sensory areas. The relative timing of this coordinated activity can indicate feedforward versus
feedback processes, revealing how perceptual decisions evolve via recurrent loops between sensation and
degree of belief in a proposition (or commitment to a plan of action). The results will yield new insights into the
representation and readout of sensory evidence and its associated degree of (un)certainty, and will advance a
population- and circuit-level understanding of decision computations in a multisensory task.

Public health relevance
Narrative This study will help us understand how the brain combines visual and nonvisual information to guide behavior and to establish cognitive states such as the degree of confidence in a decision. Our goal is to elucidate the neurophysiological mechanisms underlying visuospatial perception and decision making, and thereby pave the way for possible future treatments of disorders that affect these functions. Some of these treatments may involve complex and spatiotemporally precise manipulations of brain activity, and our studies will help refine these methods in an animal model with more human-like visual and cognitive abilities as compared to other models.